Structural-Functional Basis of Actin Cytoskeleton Dynamics

Summary
The actin cytoskeleton is a highly dynamic system consisting of hundreds of proteins. Cells use
the actin cytoskeleton to move, divide, transport organelles and exchange materials with the
environment. Many human diseases result from malfunctioning of actin cytoskeletal
components. There is therefore intense interest in understanding the molecular mechanisms
that control actin cytoskeletal processes, which has both fundamental importance and the
potential to accelerate the development of targeted therapies to treat human diseases. Among
actin cytoskeletal components, none is more important than Arp2/3 complex, a 7-subunit actin
filament nucleation and branching machinery conserved in eukaryotes from yeast to human.
This grant addresses important gaps of knowledge in the mechanisms of Arp2/3 complex
activation, inhibition, branch stabilization, and branch destabilization. Published work,
extensive preliminary studies, advances in the implementation of cryo-electron microscopy
(cryo-EM) to the study of the Arp2/3 complex regulatory system, innovative protein expression
methods, and biochemical assays provide the scientific and technical premises supporting the
research plans. The specific aims focus on three major areas: 1) understand the molecular
determinants of human Arp2/3 complex branch stability and mechanosensation using a
microfluidics-TIRF microscopy assay, 2) determine the structural-functional mechanism of
branch stabilization by Cortactin using cryo-EM and biochemical methods, and 3) uncover
whether one of the members of the coronin family acts as an Arp2/3 complex inhibitor, a branch
stabilizer, or a branch destabilizer using cryo-EM and biochemical approaches.

Public health relevance
Narrative Many human diseases result from malfunctioning of actin cytoskeletal components, including Arp2/3 complex, a 7-subunit complex involved in actin filament nucleation and branching. This project addresses important gaps of knowledge of the mechanisms of Arp2/3 complex activation, inhibition, branch stabilization, and branch destabilization, and has both fundamental importance and the potential to accelerate the development of targeted therapies to treat human diseases such as cancer.